NNLM Region 6 Regional Medical Library

The Administrative Core focuses on the following four aims: governance, membership,
collaboration, and emergency preparedness. The RML will prioritize a cooperative and
collaborative governance model that ensures education, funding, and engagement activities will
be responsive to the evolving health information needs of the Region, United States, and NNLM.
Staffing the RML will include a director, associate director, five experienced librarians, and a
communications and finance coordinator. Governance of the RML will include seven State
Stakeholder Advisory Groups consisting of a diverse and inclusive group of professionals with
expertise in a range of focus areas that align with NNLM’s target audiences, goals, and,
priorities. These Advisory Groups will establish a bidirectional communication channel within
each state and create state action plans to guide programming and services. An expanded
Partner Outreach Program will establish a “field force” of trusted NNLM ambassadors within
each state to provide greater exposure to NLM and NNLM products and services. This
community-led model will expand NNLM’s presence in the many rural and urban areas spread
out across Region 6. Both the State Stakeholder Advisory Groups and Partner Outreach
participants will contribute to membership promotion, recruitment, and engagement. Region 6
will utilize direct outreach, targeted mailings, membership kits, and membership campaigns to
recruit and engage Network members. Staff will also work cooperatively with NLM’s Office of
Engagement and Training (OET) and other RMLs, Offices, and Centers to implement best
practices regarding membership recruitment and engagement. This cooperation will extend
beyond membership into all facets of NNLM work. Region 6 staff will actively participate on
NNLM Working Groups and engage with coordinators across RMLs to identify opportunities to
develop national programming that can be delivered regionally, and vice versa. The Network
Coordinator will oversee the RML’s Emergency Preparedness and Response activities, including
the coordination of state liaisons and e-newsletter development. The Associate Director will
work with OET and other RMLs to establish protocols to ensure continuity of services in the
event that an emergency disrupts services.

Public health relevance
None required per RFA